Early Detection Of Renal Injury

1) We are continuing our work on exosomes as a source of biomarkers, including proteins and miRNA. We are exploring proper normalizing techniques for these biomarkers, including counting exosomes by Nanosight Tracking Analysis. We are also exploring subsets of urine exosomes that may derive from different segments fo the nephron.

3) We are continuing our collaboration with HESI on miRNA biomarkers for kidney and liver toxicity.

4) We are continuing our work on sepsis and sepsis-AKI with two new biomarkers, one for each.

5) We are continuing our collaboration to look at two related biomarkers that can be elevated in the plasma of COVID-19 patients.